Channelopathy of KCa2.3 and Zimmermann-Laband syndrome

ABSTRACT
Zimmermann-Laband syndrome 3 (ZLS3 [MIM: 618658]) is a rare genetic developmental disorder
characterized by gingival enlargement, developmental delay, intellectual disability, together with abnormal
fingers, fingernails, nose, and ears. Small-conductance Ca2+-activated K+ subtype 3 (KCa2.3) channels are
activated exclusively by intracellular Ca2+. There are seven human genetic mutations of KCa2.3 linked to ZLS31-
3 and one mutation associated with idiopathic noncirrhotic portal hypertension (INCPH)4. No treatment for ZLS3
exists. We recently reported that the ZLS3-related mutations in KCa2.3 increase the Ca2+ sensitivity of the
channels more than the INCPH-related mutation5. We hypothesize that disease-related KCa2.3 mutations cause
abnormally elevated Ca2+ sensitivity of the channel, a theory that will be tested in Aim 1.
To correct the abnormally elevated Ca2+ sensitivity, we will need to understand the mechanisms of how Ca2+
sensitivity is increased by the KCa2.3 mutations. These mutations can be separated into three clusters in the
channel protein1-3. The first cluster are localized at a region that we reported essential for channel gating6. The
second cluster are reported to interact with casein kinase 2 (CK2)7. CK2 phosphorylates calmodulin (CaM)
constitutively associated with KCa2.3 channels and thus negatively modulates Ca2+ sensitivity8, 9. The last
mutation, A287S, is in the transmembrane S1 domain. We postulated that the first cluster of five mutations in
KCa2.3 may enlarge the channel gate and make the channel easier to open as the mechanism for their elevated
sensitivity to Ca2+. The second cluster of mutant KCa2.3 channels may not affect the channel gate directly but
rather CK2 phosphorylation. The mechanisms for the elevated Ca2+ sensitivity of ZLS3-related mutant channels
will be elucidated in Aim 2.
As the KCa2.3 mutations elevate the Ca2+ sensitivity through differential mechanisms, the seven ZLS3-related
KCa2.3 mutations may also lead to different sensitivities to channel inhibitors. In our preliminary studies, the effect
of AP14145, a negative gating modulator, on the mutant channels was less prominent than on the wild-type
channels5, highlighting the need for compounds that inhibit mutant channels. We will explore FDA-approved
drugs and compounds in clinical trials that have been reported to inhibit KCa2.3 channels as candidates for off-
label or compassionate use in Aim 3.
PUBLIC HEALTHE RELEVANCE: There are seven human genetic mutations of KCa2.3 linked to ZLS31-3
and one mutation associated with idiopathic noncirrhotic portal hypertension (INCPH)4. We will explore FDA-
approved drugs and compounds in clinical trials that inhibit KCa2.3 channels as candidates for off-label or
compassionate use.

Public health relevance
NARRATIVE There are seven human genetic mutations of KCa2.3 linked to Zimmermann-Laband syndrome 3 (ZLS3) and one mutation associated with idiopathic noncirrhotic portal hypertension (INCPH). We hypothesize that ZLS3 is related to abnormally elevated Ca2+ sensitivity of the mutant KCa2.3 channels. We will explore FDA-approved drugs and compounds in clinical trials that inhibit KCa2.3 channels as candidates for off-label or compassionate use.